Mechanisms of Claudin-5 Regulation during Neuroinflammation

PROJECT SUMMARY
The blood-brain barrier (BBB) is a vital defender of the central nervous system (CNS) that allows for nutrient
exchange while blocking the entry of toxic factors or immune cells. However, its disruption is common in CNS
disorders and can drive their disease progression. As such, our long-term goals are to identify the mechanisms
governing BBB function and evaluate their therapeutic potential to preserve or restore BBB integrity and limit
disease progression. The overarching objective of this proposal is to investigate the role of FoxO1, nmMLCK,
and HDAC6 in BBB dysfunction and disease progression using animal and cell culture models of multiple
sclerosis (MS), a chronic CNS disorder affecting an estimated one million adults in the US. During barrier
maturation, the transcription factors FoxO1 and β-catenin are inactivated and removed from a silencer region in
the Cldn5 promoter. However, we have shown that inflammation-induced BBB-dysfunction requires their
concurrent re-activation and occupancy at the silencer region. This process involves nmMLCK. In a follow-up
study, we defined an insulin receptor (IR)-Akt2-FoxO1 axis that can be targeted with an IR agonist to limit FoxO1
activation, claudin-5 loss, and barrier dysfunction in BBB-ECs and mice induced with experimental autoimmune
encephalomyelitis (EAE), a model of MS. Here, we provide preliminary data showing the importance of nmMLCK
and its regulation by histone deacetylase 6 (HDAC6) in barrier dysfunction. Global knockout mice are resilient to
EAE, including paralysis, BBB dysfunction, and claudin-5 loss. In tandem, we explored mechanisms for nmMLCK
activation and identified that it is robustly deacetylated in IL-1ꞵ-stimulated BBB-ECs. Using inhibitors, we found
that tubastatin A attenuated barrier dysfunction, implying that HDAC6 is responsible. Thus, we hypothesize that
FoxO1 and β-catenin are essential for mediating inflammation-induced claudin-5 repression, driving BBB
dysfunction. To address this, we have developed a two-part approach that focuses on the relative contributions
of FoxO1 deficiency in BBB-ECs (Aim 1) and HDAC6/nmMLCK/β-catenin signaling-dependent downregulation
of claudin-5 (Aim 2) to BBB disruption and disease progression. The multi-faceted approach combines in vivo
physiological analyses in EAE with complementary co-culture systems using BBB-ECs, astrocytes, pericytes,
and myelin-reactive T cells. Multiple innovative models are proposed, including transgenic mice with inducible
BBB-EC-specific knockout of FoxO1, nmMLCK, or HDAC6 and pharmacologic approaches to inhibit them; new
molecular tools like TetOn overexpression systems for FoxO1 and HDAC6; and state-of-the-art histopathology
techniques to detect and characterize perivenular inflammatory lesion formation which occurs around CNS
microvessels in white matter lesions. In sum, the proposed research is significant, as data derived from these
studies will provide new mechanistic insights into the pathophysiology of BBB dysfunction during inflammation,
which has the potential to provide a basis for developing new therapeutic targets for CNS disorders that involve
BBB dysfunction.

Public health relevance
PROJECT NARRATIVE The progression and perpetuation of neuroinflammation-associated diseases in the central nervous system affect various conditions such as multiple sclerosis (MS), stroke, traumatic brain injury, dementia, encephalopathies, and brain metastases, which impact the lives of 9 million individuals in the United States and carry an annual cost burden of 300 billion dollars. Our hypothesis is that three key molecules, FoxO1, nmMLCK, and HDAC6, are involved in signaling mechanisms that trigger the loss of blood-brain barrier (BBB) integrity during neuroinflammation. In our proposal, we aim to: 1) define the cellular and molecular mechanisms for how these molecules contribute to the loss of the tight junction protein claudin-5 in BBB endothelial cells, which provides the physical and immune barrier properties of the BBB, and 2) evaluate the therapeutic potential of reversing this loss to preserve BBB integrity and limit disease progression using complementary animal and cell culture models of MS.